CYTOF AND O-LINK ASSESSMENT IN THE `NCI COVID-19 IN CANCER PATIENTS STUDY' (NCCAPS)

The primary objective of this project is to study the immune response to COVID-19 in patients with cancer by assessing the cellular compartment of the immune system using mass cytometry by CyTOF and cytokines by O-link profiling.